Activation of Phospholipase Cbeta by G Proteins

DESCRIPTION (provided by applicant): P.I. S. Scarlata Phospholipase C-b (PLCβ) enzymes are activated by G proteins in response to agents such as hormones and neurotransmitters. PLCβ activity causes an increase in intracellular calcium which ultimately leads to profound changes in the cell. Our lab has focused on the mechanism through which G proteins activate PLCβ on the molecular level. However, in cultured cells, we find additional and unexpected mechanisms of regulation. First, membrane domains called caveolae can control the duration of PLCβ activation by selectively sequestering G protein activators. 1 - In AIM 1, we will use live cell imaging and state of the art fluorescence methods to determine the mechanisms through which caveolae prolongs PLCβ - mediated calcium signals and directs signals along specific cellular pathways. 2- We have found that PLCb localizes to the nucleus and cytosol as well as the plasma membrane where its G protein activators are found. We have identified a novel protein partner of PLCβ translin-associated protein X (TRAX). TRAX and its partner translin are major components of the siRNA machinery regulating the cellular levels of proteins. In AIM 2, we will determine the ability of TRAX to deliver PLCβ from the nucleus to the plasma membrane upon G protein activation. In parallel, we will determine whether PLC affects translin-TRAX function. 3- The ability of PLCβ to generate signals depends on its cellular concentration. We have found that the synucleins can binds to and stabilize PLCβ in cells. Alpha-synuclein (AS) is a small unfolded protein of unknown function and is a major component of neurodegenerative plaques. The presence of AS greatly increases PLCβ levels, and we find that down-regulation of PLCβ?causes AS aggregation. Also, gamma- synuclein (GS), the protein encoded by the breast cancer susceptibility gene 1, appears to increase PLCb -mediated migration and cell invasiveness thereby promoting breast cancer. In AIM 3 we will better define PLCβ - synuclein interactions and develop reagents that prevent AS aggregation and reduce GS-induced breast cancer phenotype. PUBLIC HEALTH RELEVANCE: P.I. Scarlata, S. Project Narrative In cells, enzymes are subject to other forms of regulation that are distinct and not seen in vitro. Here, we will continue our studies of the activation of phopsholipase C-2 (PLC2) focusing on its cellular regulation which may be applicable to other enzymes. Importantly, the link between PLC2 and synucleins in promoting neurodegenerative disease and breast cancer will be explored to develop more effective therapeutics.

Public health relevance
P.I. Scarlata, S. Project Narrative In cells, enzymes are subject to other forms of regulation that are distinct and not seen in vitro. Here, we will continue our studies of the activation of phopsholipase C-β (PLCβ) focusing on its cellular regulation which may be applicable to other enzymes. Importantly, the link between PLCβ and synucleins in promoting neurodegnerative disease and breast cancer will be explored to develop more effective therapeutics.